Administrative Core

Aim 1: Provide Scientific Leadership: Scientific decision-making is the responsibility of the Project Director/Principle Investigator after consultation with the Project/Core leaders and discussion at our regular meetings linked with consensus building. The administrative Core will also be the interface and will seek guidance from the Internal and External Advisory Committees Aim 2: Communication/Conferences: The key role of the Administrative Core is to establish efficient communication as it relates to the dissemination of scientific data/discoveries. Our success will be dependent on the active and open communication process between the members of the POl at all levels. The Administrative Core will pursue an active interaction with the Internal and External Advisory Committees and NIH and the office of Sponsored Programs itself. At specific intervals we will have a Strategic Meeting to set the direction for the next Quarter and plan for the Internal and External Advisors visits. The administrative Core will also coordinate the preparation of the progress reports for NIH prior to the joint External/Internal Advisory Committee meetings. Aim 3: Budget Management: Oversee the financial and conduct of the overall POl. Projects leaders will have responsibility for managing their individual budgets, with summaries provided by Core A. Core A will prepare budget summaries for presentation to the Pi's and Core directors. Aim 4: IRB/IACUC/Safety: Helping with Animals and Human Subjects, and Safety Committees re-approval.

Public health relevance
The Administrative Core will continue provide leadership for the smooth conduct of the 3 projects and 2 cores. This includes facilitating proper communication within the PPG and with NIH and the University in general. To this end the model we have adhered to for the past 10 years has many proven strengths as demonstrated by the outstanding productivity of the POl to date. Division of Reproductive Sciences and our department have synergized with an excellent group of established scientists to ensure outstanding success.